Chemical Biology Probes to Decipher Regulation of TRPV1 in Living Cells

In this proposal, we apply new chemical biology tools to probe the molecular and cellular
mechanisms by which the inflammatory mediator nerve growth factor (NGF) regulates the
trafficking of TRPV1 ion channels. Although genetically encoded fluorescent proteins have
facilitated major breakthroughs, they can perturb protein trafficking and do not clearly distinguish
protein in the plasma membrane from that in intracellular compartments. To overcome these
limitations, we developed novel tetrazine-based noncanonical amino acids and evolved
aminoacyl tRNA synthetases to incorporate them into proteins in mammalian cells via amber
codon suppression. We also developed membrane-impermeant, fast-reacting strained trans-
cyclooctene-conjugated fluorophores that react with the tetrazine noncanonical amino acids on
the extracellular side of proteins within seconds, even at sub-micromolar concentrations
compatible with cell imaging. We utilize these new chemical biology probes to probe the cellular
and molecular mechanisms by which NGF signaling increases TRPV1 trafficking to the plasma
membrane. NGF binds to a receptor tyrosine kinase, which then activates multiple signaling
pathways including phosphoinositide 3-kinase (PI3K). We combine genetic code expansion and
bio-orthogonal labeling with our recently published system for activating PI3K. This “OptoPI3K”
system bypasses the NGF receptor to activate PI3K directly, without activating other signaling
pathways. We will use genetic code expansion and our new, rapid click chemistry labels to
determine the cellular mechanisms by which NGF promotes trafficking of TRPV1 channels to
the PM (Aim 1). We will activate OptoPI3K with light to determine the role of the positive
feedback of TRPV1 on PI3K and whether other pathways contribute to the NGF response (Aim
2). We will use multi-color single-molecule imaging with our bright, photostable click chemistry
labels to determine how NGF regulates the complex that includes TrkA, PI3K, and TRPV1 (Aim
3). Finally, we will generate mutations in TRPV1 to disrupt the PI3K interaction and determine
the role of the interaction in NGF-induced sensitization (Aim 4). The approaches we apply to this
system will be broadly useful for studying signaling via G-protein coupled receptors and receptor
tyrosine kinases in a variety of cell contexts.

Public health relevance
Project Narrative TRPV1 ion channels mediate pain in the cornea and peripheral nervous system become even more sensitive to noxious stimuli during inflammation. This project uses novel chemical biology tools to reveal mechanisms by which inflammatory mediators increase pain sensitivity to develop potential new targets for pain therapies.